Research Assessment Services Core

Research Assessment Services Core
Center for Bio-behavioral Mechanisms of Eating Behavior
SUMMARY/ABSTRACT
We propose to establish a Center of Biomedical Research Excellence (COBRE) at the Sanford Center for Bio-
behavioral Research, the University of North Dakota School of Medicine, and the North Dakota State University
(NDSU) Department of Psychology and Department of Pharmaceutical Sciences, which focuses on conducting
innovative, state-of-the-art eating disorders and eating behavior research. The purpose of the Research
Assessment Services Core is to make available integrated, multi-level assessment methodologies to the Project
Directors, students, and university system researchers. This core will provide access to cutting-edge
assessment methodologies, consultation and technical support for these methodologies, and theoretical and
scientific support. In the current application we describe training in assessment methodology, resources and
expertise in multi-level assessment methodology, and the development of a comprehensive center of research
excellence in eating disorders and eating behavior.